Genomics of rapid adaptation in the lab and in the wild

Project Summary
Adaptation is the foundational concept in biology. My lab aims to build an empirically and theoretically rich theory
of adaptation. We focus specifically on the inference of adaptation from genomic data and on the study of rapid
evolution in real time. The latter include (i) experimental evolution in yeast (adaptation by de novo mutation in
well-mixed clonal system), (ii) adaptation on seasonal and ecological time-scales in Drosophila (adaptation from
standing variation in a obligately sexual organism), and (iii) inference of adaptation from well resolved population
genomic and phylogenetic data. These projects utilize a diversity of systems, high throughput and well-powered
experimental modalities, and sophisticated and varied analytic frameworks, but they all focus on the overarching
need to understand the dynamics of rapid adaptation. The reduction in the cost of sequencing is making it
possible and imperative to increase the resolution through the increase in the number of replicates and this in
turn requires the application of liquid handling robotic systems as the one I am requesting here.

Public health relevance
Project Narrative Evolutionary adaptation is the foundation concept in biology and is at the center of many problems facing humanities such as cancer, infectious disease including the jumps of viruses from other species to humans, and drug resistance. Using a series of related projects the Petrov lab will pursue empirical, computational, and theoretical research aimed at building a rich predictive and quantitative theory of adaptation using scalable and very high throughput approaches.